Proteomic biomarkers for radiation injury and countermeasure efficacy

The overall objective of this research project is to determine proteomic biomarkers of irradiation in preclinical experimental models of non-human primates (NHP). These data may permit prediction of treatment outcomes for individuals exposed to γ-radiation over the long term. Additionally, such biomarkers may help identify molecular targets useful for the development of promising radiomitigators.